A Stress Inducible Protein Sestrin2 in Heart Failure

Heart failure is an increasingly prevalent problem and particularly so amongst an aging Veterans
population. From a clinical standpoint, the prevalence of comorbid conditions such as obesity, diabetes,
COPD (chronic obstructive pulmonary disease), aging and hypertension in these patients has led to the
inflammatory hypothesis where heart failure is also associated with coronary microvascular dysfunction.
Nevertheless, the causal importance of maladaptive substrate metabolism and impaired coronary flow
regulation in the development of the heart failure remain unclear. The work described in this proposal
combines experiments at the basic and translational research level to address the critical need of our
veterans for novel and effective heart failure therapies. The long-term goal of our research is to
understand the molecular mechanisms that underlie the role of Sestrin2 (Sesn2), a stress inducible
protein, in mediating progression from compensated left ventricular hypertrophy to decompensated
hypertrophy and maladaptive ventricular remodeling in heart failure. We have demonstrated that Sesn2 is
a mediator of physiologic and pathologic cardiac hypertrophy and are now seeking to define the
underlying molecular mechanisms. Sesn2 knockout (Sesn2 KO) mice display normal cardiac function at
rest compared to wild type (WT) littermates but are vulnerable with pathologic hypertrophy in response to
pressure overload. Furthermore, recently published data from our lab show that Sesn2 serves as an age-
related protein that modulates AMPK, a cardiac energy sensor, to maintain metabolic homeostasis under
stress conditions. Aging related heart failure could be due to impaired Sesn2-AMPK signaling cascade
occurring in synergy with the adverse effects of hypertension. Thus, our central hypothesis is that Sesn2
serves as a scaffold protein that plays a key role in hypertension induced heart failure in aging. Aim 1: To
determine the upstream signaling pathways that control cardiac Sesn2 expression, and the mechanisms
by which Sesn2-mediated AMPK signaling inhibits development of hypertension-induced heart failure in
aging. Aim 2: To determine the role of Sesn2-mTORC1 complex in the cardiac response to hypertension
and aging. Our long-term objective is to improve the care of Veterans with heart failure by developing a
better understanding of the mechanisms leading to heart failure and identifying novel targeted treatments
that can prevent or reverse hypertensive heart failure.

Public health relevance
With aging along with prevalent risk factors such as diabetes, COPD, obesity, hypertension, and heart failure. While we have made great advances in the drugs and devices available to treat heart failure in adults, they do not work in elderly patients with this condition. The research proposed in this application will attempt to fill this critical gap by studying age-related impairment in the adaptive response that occurs during heart failure. The proposed research will highlight new therapeutic targets and further our understanding about how alterations in glucose and fatty acid metabolism occurred with aging in a preclinical model of heart failure. The outcome of the studies could provide a basis for improving contractile function and have a major impact on symptoms, disability, and survival of Veterans with heart failure.